Administrative Core

This U19 Asthma and Allergic Diseases Cooperative Research Center (AACDRC) Program brings together a
team of investigators in three interactive projects and two cores to focus on the pathobiology of specific innate
immune mechanisms in viral infection and asthma. In the renewal of our AADCRC program, we will continue
to focus on the critical and often understudied innate immune factors surfactant protein-A (SP-A), the
anion lipids of surfactant, (palmitoyl-oleoyl-phosphatidylglycerol (POPG) and phosphatidylinositol (PI))
and Toll interacting protein (Tollip), an innate immune mediator known to cross talk with SP-A and the
anionic lipids. Each of these mediators works synergistically to modulate inflammatory and immunologic
responses in asthma and infection given their complementary functions. Our exciting preliminary data underpin
our program’s overall hypothesis that POPG/PI, Tollip and SP-A function as unique immune modulators
that attenuate the impact of specific viral infections (RV-C, Influenza A and SARS-CoV-2) in type-2
asthma. The investigators in this program have a long history of collaboration at the. University of Arizona and
National Jewish Health; Cedar Sinai Medical Center is now included in this renewal. The Administrative Core
(Core A) of this Program will perform an important role to maintain productive and vibrant collaboration, ensure
and track adherence to NIH and other relevant regulations and guidelines, and manage activities that will
continue to strengthen the research community surrounding this Program. The Administrative Core has the
following Specific Aims: (1) Manage the day-to-day administrative details and programmatic needs of the
AADCRC program by providing fiscal management, administering subcontracts, assuring that regulatory
requirements in are met, and monitoring of progress with program objectives; (2) Create an infrastructure to
facilitate communication between the projects, cores and. investigators, and NIH Program Directors and to
provide conflict resolution should it be necessary; (3) Assist with dissemination of research findings in a timely
fashion to the scientific community, both locally and nationally, and provide information to the public, including
study participants; 4) Implement the Infrastructure and Opportunity Fund for the AADCRC. Our proposal builds
upon our active and productive collaborations of over 20 years and will significantly enhance our understanding
of the innate molecular mechanisms underlying the interaction between type 2 inflammation in and viral
exacerbations of asthma. The strong synergy among our projects will accelerate progress toward novel
therapies by demonstrating that the innate immune components under study protect against viral
infection in asthma.